IGF::OT::IGF TASK ORDER 26: SUPPORT WITHIN THE DIVISION OF CANCER CONTROL & POPULATION SCIENCES (DCCPS), OFFICE OF THE DIRECTOR (OD).

Support within the Division of Cancer Control & Population Sciences (DCCPS), Office of the Director (OD).